Mitochondrial Dysfunction in Aging CD4 T cells in HIV-immune Non-responders.

SUMMARY - Mitochondrial Dysfunction in Aging CD4 T Cells in HIV Immune Non-Responders
Despite effective control of HIV by antiretroviral therapy (ART), a significant number of HIV patients fail to achieve
complete immune reconstitution and are deemed immune non-responders (INRs). CD4 T cells from these HIV-INRs
exhibit prominent mitochondrial dysfunction and premature aging, which play a major role in HIV latency and
increase the incidence of non-AIDS, non-communicable diseases (NCDs). To date, how CD4 T cells develop
mitochondrial dysfunction and premature aging is unknown, thus raising an urgent need to uncover these molecular
processes. The objective of this administrative supplemental proposal is to elucidate the mechanisms that drive
mitochondrial dysfunction in aging CD4 T cells during HIV infection. During our parent award entitled “HIV infection-
induced mitochondrial dysfunction and premature T cell aging”, our studies revealed significant changes in
mitochondrial functions in aging CD4 T cells from HIV patients (especially in INRs), including decreases in
mitochondrial respiration, ATP production, and mitochondrial (mt)DNA content, and increases in the synthesis of
reactive oxygen species (ROS) and expression of aging markers. Importantly, we found that these functionally
impaired, aging CD4 T cells display significant repression of peroxisome proliferator-activated receptor-gamma
coactivator 1 alpha (PGC1α) and mitochondrial transcription factor A (mtTFA) - two mitochondrial master regulators
- along with differential expression of specific non-coding RNAs (ncRNAs), which control the expression of target
genes at the post-transcriptional level. Based on these new findings, we further hypothesize that mitochondrial
regulatory proteins PGC1a and mtTFA are epigenetically dysregulated by ncRNAs during HIV infection, leading to
mitochondrial dysfunction and CD4 T cell aging. We propose two aims to test this hypothesis. Aim 1 will investigate
how PGC1α and mtTFA are repressed in CD4 T cells during latent HIV infection. Aim 2 will determine the impact of
PGC1α and mtTFA repression on CD4 T cell aging during latent HIV infection. This translational research is novel
and will answer clinically relevant questions: how HIV infection induces mitochondrial dysfunction and aging in CD4
T cells; and whether targeting the mitochondrial regulatory machinery can restore mitochondrial functions and
reprogram the CD4 T cell aging process. Information gained from this study will fill major knowledge gaps in
understanding of the pathogenesis of HIV latency and facilitate the development of novel HIV immunotherapy. Thus,
this proposal is significant and will have a potentially high impact on HIV and aging research. Because this
administrative supplemental application is based on our funded parent project, will add participants (including elderly
Veterans) with HIV to our ongoing study where such participants were not enrolled in sufficient numbers to make
meaningful comparations between groups for exploration of new measures to elucidate the role and mechanisms of
master mitochondrial regulators in T cell mitochondrial regulation, this administrative supplemental application is
relevant to HIV and aging research, meets the eligibility criteria, and fits within the scope of our existing award.

Public health relevance
NARRATIVE Patients with HIV infection (especially those immune non-responders/INRs) exhibit profound mitochondrial dysfunction and premature CD4 T cell aging, which play a major role in HIV latency and contribute to the development of non-AIDS, non-communicable diseases (NCDs). To date, the mechanisms underlying mitochondrial dysfunction and T cell aging during HIV latency remain unclear. In this proposal, we will investigate the mechanisms of mitochondrial dysfunction and T cell aging in patients with latent HIV infection. This study will enhance our understanding of the fundamental mechanisms underlying immune aging which is essential for developing effective means to restore immune competence in patients with latent HIV infection. It is thus significant, timely, and important to public health.